CHANGES IN CERVICAL DILATATION AND PROGRESS IN LABOR

The amplitude, duration, interval, rate of rise and fall of 10 uterine contractions and corresponding changes in the cervical dilatation during active labor with a nominal dilatation of 5 cm are being measured with an ultrasonic cervimeter. The goal of this protocol is to determine if any of these variables or combinations of variables are predictive of the outcome and/or subsequent duration of labor.